A platform for therapeutic agents that promote rapid recovery from botulism

DESCRIPTION (provided by applicant): Botulism is caused by exposure to toxins produced by Clostridium botulinum neurotoxin (BoNT), a CDC Category A biodefense threat agent for which no antidote currently exists. Seven different BoNT serotypes have been discovered to date (BoNT/A-G), many having numerous additional BoNT subtypes. To protect against all of these diverse BoNT bioterror threats, expensive conventional small molecule drug development would need to be separately performed for each of the seven different drug targets and perhaps others. This challenge, together with other extreme hurdles confronting BoNT small molecule drug development, particularly complicates efforts to develop small molecule drugs to treat botulism. New therapeutic paradigms are urgently needed to counter the enormous risks associated with these easy to obtain, easy to produce and extremely dangerous bioterror agents. We have developed and then extensively optimized two distinct 'designer E3-ligase' agents that each accelerate the 'molecular cure' of neurons intoxicated by one of the two most dangerous Botulinum neurotoxins, serotypes A or B (BoNT/A, BoNT/B). These two lead agents consist of the F-box domain of TrCP fused to a camelid 'nanobody' domain with binding specificity for one of the BoNT proteases. These polypeptide agents, with a size less than 30 kDa, bind to the BoNT protease and cause its rapid, intraneuronal destruction leading to rapid recovery of the neuron. Because of the modular nature of this antidote, it will be simple and straightforward to develop similar agents to treat all other BoNT serotypes and subtypes simply by substituting the nanobody domains with another having the appropriate specificity. In this proposal, we will develop a general delivery vehicle to deliver our two lead agents to the cytosol of intoxicated neurons within botulism patients and perform pre-clinical evaluation. As the vehicle, we propose to use an atoxic Clostridial toxin-based neuronal delivery vehicle (TNDV) due to its highly evolved capability to enter the body, survive in serum and deliver enzyme activities to the cytosol of targeted cells. We will develop three different and proven TNDV systems, each having unique and compelling features, and then select the best vehicle(s) for further development and animal testing. The three TNDV systems will be modified, atoxic forms of: 1) BoNT serotype C; 2) C. difficile toxin B and; 3) Clostridial C2 toxin. If successful, it is expected that similar agents could be developed to target the accelerated turnover of virtually any cytosolic neuronal protein for research or therapeutic applications.

Public health relevance
Public Health Relevance: Botulinum neurotoxin is an extremely dangerous, CDC Category A biodefense threat that is widely available, easily produced, exceedingly toxic and for which no antidote is available. Furthermore, at least seven different toxin types exist, each constituting of different drug targets and thus requiring distinct, challenging and expensive small molecule drug development programs. In contrast, the innovative new platform for biomolecule therapeutics that we propose to develop has the potential to quickly lead to commercially viable antidotes for all BoNT serotypes. Relevance. Botulinum neurotoxin is an extremely dangerous, CDC Category A biodefense threat that is widely available, easily produced, exceedingly toxic and for which no antidote is available. Furthermore, at least seven different toxin types exist, each constituting different drug targets and thus requiring distinct, challenging and expensive small molecule drug development programs. In contrast, the innovative new platform for biomolecule therapeutics that we propose to develop has the potential to quickly lead to commercially viable antidotes for all BoNT serotypes. __SpecificAimsTextDelimiter__ Specific Aims Botulism is caused by exposure to toxins produced by Clostridium botulinum neurotoxin (BoNT), a CDC Category A biodefense threat agent for which no antidotes exist. Seven different BoNT serotypes have been discovered to date (BoNT/A-G), many having numerous additional toxin subtypes. This diversity in BoNT effectively means that, to protect against all potential bioterror threats, agents must be developed that are specific to a wide variety of different drug targets. This challenge, together with the extremely large substrate/enzyme interface, particularly complicates efforts to develop small molecule drugs to treat botulism. New therapeutic paradigms are urgently needed to counter the enormous risks associated with this easy to obtain, easy to produce and extremely dangerous bioterror agent. We have developed and then extensively optimized two distinct 'designer E3-ligase' agents that each accelerate the 'molecular cure' of neurons intoxicated by one of the two most dangerous Botulinum neurotoxins, serotypes A or B (BoNT/A, BoNT/B). These two lead agents consist of the F-box domain of TrCP fused to a camelid 'nanobody' domain with binding specificity for one of the BoNT proteases. These polypeptide chimeric agents, with a size less than 30 kDa, bind to the BoNT protease and cause its rapid, intraneuronal destruction leading to rapid recovery of the neuron. Because of the modular nature of this antidote, it will be simple and straightforward to develop similar agents to treat all other BoNT serotypes and subtypes simply by substituting the nanobody domains with another having the appropriate specificity. In this proposal, we will develop a general delivery vehicle to deliver the lead agents to the cytosol of intoxicated neurons within botulism patients and perform pre-clinical evaluation. As the vehicle, we propose to identify the most effective of three different and proven Clostridial toxin-based delivery systems: 1) atoxic BoNT toxin, serotype C (aBoNTC); 2) atoxic Clostridium difficile toxin B (aTcdB) and; 3) atoxic Clostridial C2 toxin (aC2). These Clostridial toxins are ideally suited for this purpose since they each have highly evolved capabilities to gain entry into animals, survive in blood, bind to receptors on specific cells, penetrate the target cell, and deliver an enzymatic activity to the cytosol. Once the best toxin-based neuronal delivery vehicle (TNDV) is identified, we will test it for the ability to deliver our designer E3-ligase lead agents to intoxicated neurons and to accelerate motor function recovery in two animal models. Our proposed Specific Aims are: Aim #1. Engineer, express and safety-test three toxin-based neuronal delivery vehicles (TNDVs) for delivery of lead candidates to intoxicated neurons. We will generate atoxic mutants of BoNT/C, TcdB and C2 toxins, optimize recombinant expression and test their safety in mice. Aim #2. Produce each of the three recombinant TNDVs fused to our two lead candidates in different formats and measure reversal of BoNT intoxication in cultured primary neurons. Efficacy will be assessed by restoration of SNARE protein integrity and/or neurotransmitter release in BoNT/A or BoNT/B intoxicated neuronal cells. Aim #3. Test the most efficacious agents from Aim #2 for their ability to restore muscle function in mice and rabbit models of BoNT/A or BoNT/B paralysis. Aim #4. Perform preliminary dosing, route of administration, toxicity and pharmacokinetic evaluations of the best agents identified in Aim #3. If our Aims are achieved, we will have substantially developed an agent with the potential to reverse BoNT/A and BoNT/B intoxication in patients- likely with a single dose. Importantly, we will also have, in hand, a platform that can lead to rapid development of agents to cure botulism caused by each of the remaining five toxin serotypes as well as to 'enhanced' or 'advanced' BoNT agents that may be encountered. Currently there is not a single countermeasure available to treat patients with botulism despite the enormous bioterror threat posed by this toxin class. Furthermore, we will have developed a targeted biomolecular delivery system likely to have applications in therapies for a wide variety of other medical conditions. Finally, we will have created a new strategy to perform specific, designed modifications within targeted cells, useful for both research and therapeutic applications.